Modernization of the Pancoe Cage Wash Facility with a New Soiled Bedding Removal System

Project Summary
The Center for Comparative Medicine (CCM), at Northwestern University, is the university-wide
animal care and housing unit. CCM houses a wide variety of research animal species and
supports cage washing facilities on both the Evanston and Chicago campuses. CCM’s 19-year-
old Pancoe cage washing facility is the sole cage washing facility on the Evanston campus.
Plans are underway to renovate this cage washing facility, providing an opportunity to find a
solution to the manual soiled bedding removal process. Currently CCM staff are manually
dumping soiled bedding from cages, using a down draft dump station, which collects the soiled
bedding into bagged bins. The bins are then manually lifted, and soiled bedding bags are
dumped into bulk carts. The heavy bulk carts, filled with soiled bedding waste, are then
manually transported several times a day, through public hallways and elevators to a dumpster
located on a dock in an adjoining building. The objective of this project is to modernize and
improve the soiled bedding handling of the Pancoe cage wash facility, through the purchase of a
new Northwestern Systems Corp Sure-Flo S200 Series Soiled Bedding Removal System. This
soiled bedding removal system utilizes a tubular drag-chain design. This design uses a
continuous series of discs pulled through a transport pipe to convey soiled animal bedding and
materials from the cage washroom to a designated waste container room. This soiled bedding
removal system will reduce manual processes, thereby increasing the overall cage handling
capacity and operational efficiencies of the Pancoe cage wash facility. Additionally, this new
equipment will reduce potential for employee injury and allergen exposure, because the dump
station will be designed with a downdraft unit that captures dust and allergens, when integrated
with the dust collection unit. The soiled bedding will be immediately contained and conveyed
through the piping into contained bulk carts, thus eliminating a significant amount of movement
of the heavy soiled bedding bulk carts through corridors. National Institutes of Health funding of
this proposal will in these ways benefit investigators as well as by increasing overall cage
handling capacity, thereby allowing research programs to grow and new faculty to be recruited
to the university.

Public health relevance
Project Narrative It is critical for cage washing facilities to have an operationally efficient and safe mechanism to remove soiled bedding waste from an animal facility. The Center for Comparative Medicine (CCM) is applying to purchase a Northwestern Systems Corp Sure-Flo S200 Series Soiled Bedding Removal System to help modernize this process in the CCM Pancoe cage washing facility. The purchase of this equipment will contribute indirectly to the overall advancement of scientific research by allowing CCM staff more efficiently and safely increase the volume of cage processing for research use, enabling the university's research programs to grow and new faculty to be recruited.